Discovery and characterization of a novel natural product for the treatment of both diabetes and obesity

Project Summary
Despite the wide application of commonly used drugs for type 2 diabetes (T2D) treatment, the prevalence of
T2D continues to rise in the US. Insulin resistance and progressive decline in functional β-cell mass are two key
driving forces for T2D. Obesity is a leading pathogenic factor for developing T2D, which is a significant obstacle
for effective glycemic control in many patients with T2D. Thus, identifying novel agents that can simultaneously
ameliorate obesity and promote insulin sensitivity and β-cell function would be a more effective strategy for
preventing and treating T2D. In searching for agents with both anti-obesity and anti-hyperglycemic activities, we
found for the first time that elenolic acid (EA), a small molecule generated from hydrolyzing olive leaf-derived
oleuropein, is such a highly promising compound. Excitingly, oral administration of EA reversed hyperglycemia
while also promoting weight loss and suppressing food intake in obese diabetic mice, Notably, EA was more
effective in managing hyperglycemia and obesity than that of metformin. Interestingly, EA induced peptide YY
(PYY) and glucagon like peptide-1 (GLP-1) secretion from intestinal L-cells. In this grant, we propose to test
hypothesis that EA is a dual acting agent for simultaneous treatment of obesity and diabetes via triggering PYY
and GLP-1 secretion. Aim 1 will characterize the anti-diabetic and anti-obesity effects of EA. In that regard, diet-
induced obese mice and obese diabetic db/db mice will receive EA treatment once daily via oral gavage. The
effects of EA on metabolic profiles of obese diabetic mice will be examined for determining its anti-obesity and
anti-diabetic efficacy. In addition, euglycemic-hyperinsulinemic clamps in combination with ex vivo analyses of
peripheral tissues will be performed to examine the effects of EA on insulin action, fat metabolism, and
gluconeogenic programs. Immunohistochemistry will be carried out to analyze Islet β-cell mass and function.
Further, oral bioavailability, metabolism, and potential toxicity of EA will be studied. Lastly, mouse models with
T2D will be used to investigate the synergistic metabolic effects of EA plus metformin combination therapy. Aim
2 will identify the mechanisms by which EA suppresses food intake and protects against obesity. First, the effects
of EA on feeding responses and stomach emptying in mice will be evaluated, followed by ex vivo analyses of
hypothalamic pathway controlling food intake. Next, pair-feeding in combination with energy expenditure
analyses will be performed to examine the extent to which the anti-obesity efficacy of EA is driven by reduced
energy intake. Additionally, intracerebroventricular administration of pharmacological inhibitors targeting GLP-1
receptor (GLP-1R) or PYY receptor (Y2R) as well as the receptor null mice will be used to investigate whether
EA inhibition of food intake requires the central PYY/Y2R and/or GLP-1/GLP-1R signaling systems. The results
of this project are expected to defining the efficacy of a novel compound for treating both diabetes and obesity
as well as uncovering the mechanism underpinning these effects, which will potentially lead to developing new,
safe, and effective therapy for battling both diabetes and obesity.

Public health relevance
Project Narrative Type 2 diabetes (T2D) is a growing public health problem in the U.S., which presently affects at least 37 million Americans with an estimated 1.4 million new cases diagnosed very year. It is primarily caused by obesity- associated insulin resistance and dysfunction of insulin producing beta-cells. This research is aimed at identifying and developing safe and low-cost agents that simultaneously promote weight loss and reverse T2D.